Competing Revision: Adding costing activities to the Tu'Washindi Study

PROJECT SUMMARY/ABSTRACT
The parent study to this competing revision application (R01MH125671) aims to test the effectiveness of a multilevel
community-based intervention to increase uptake and adherence to oral pre-exposure prophylaxis (PrEP) among
adolescent girls and young women (AGYW) in Siaya County, Kenya. This competing revision seeks to expand the
scope of the parent study by adding a cost and economic evaluation. AGYW in this setting live in a context of
heightened gender inequality and risk of intimate partner violence (IPV) and represent a large subpopulation uniquely
vulnerable to HIV infection. In addition to having higher HIV incidence, women experiencing IPV are less likely to
initiate and persist with PrEP, limiting the protective benefit of this efficacious biomedical prevention intervention.
Tu’Washindi na PrEP (We are Winners with PrEP) is a multilevel, community-based intervention designed specifically
to address these challenges among AGYW. Designed by our team using participatory methods engaging local AGYW
(R34 MH114519), the intervention includes three components delivered over 6 months: an eight-session,
empowerment-based support club for AGYW, community sensitization targeted toward male partners, and PrEP
education events for couples. Activities are designed to be integrated into youth-focused programming to ensure
efficiency and sustainability. Results from a pilot cluster-randomized controlled trial conducted with 103 AGYW at six
sites indicate high feasibility and acceptability and preliminary effectiveness: intervention arm participants had 2-fold
higher PrEP uptake and adherence (p<0.05), with less frequent or severe IPV than control arm participants. The current
study builds on these promising results to evaluate the intervention in a fully powered cluster-randomized controlled
trial across 22 administrative wards in Siaya County, enrolling 72 AGYW per ward (N=1,584). The primary objectives
(Aim 1) are to test the effectiveness of the intervention on PrEP uptake and adherence immediately post-delivery
(month 6 post-enrollment) and 6 months later (month 12). A secondary objective is to test the intervention effect on IPV
(Aim 2). A rigorous process evaluation is exploring mechanisms of change, contextual factors, and implementation
considerations to inform future refinement and scale-up, using programmatic data, participant questionnaires, and
qualitative interviews with participants, providers, and male partners (Aim 3). However, the process evaluation does not
collect data on the cost and affordability of intervention implementation. During stakeholder engagement, it has become
clear that intervention cost and affordability will be important considerations in determining whether Tu’Washindi is a
good candidate for scale-up. Therefore, we propose a new Specific Aim to the current study (Aim 4): To measure the
costs of implementing Tu’Washindi and perform a budget impact analysis to understand the resources required for
successful implementation. The cost and budget impact data generated in this competing revision will complement data
from our process evaluation to inform policy and practice and ensure that, if effective, Tu’Washindi can be rapidly and
sustainably integrated into existing youth-focused HIV prevention programming to expand and support PrEP uptake
and adherence in this priority population.

Public health relevance
PROJECT NARRATIVE The proposed revision will collect costing data for our youth-designed, community-based intervention to address barriers to pre-exposure prophylaxis (PrEP) use faced by adolescent girls and young women in inequitable relationships and subject to intimate partner violence in Kenya. Combined with effectiveness and process evaluation results from the parent study, these data will fill a gap in the limited evidence base for interventions to expand PrEP uptake and adherence in this priority population and facilitate rapid translation from research to practice.